EFFECTS OF RICE BASED ORAL REHYDRATION THERAPY ON ELDERLY

The major goal of this study is to determine alterations in intestinal absorption and intestinal protein loss in the elderly treated with rice-based oral rehydration solution during diarrhea and upon recovery.